Tissue Immunity

ABSTRACT Support is requested for a Keystone Symposia conference entitled Tissue Immunity, organized by Drs. Bana Jabri, Daniel Mucida and Ramnik Xavier. The conference will be held in Boulder, Colorado from January 26- 29, 2020. How tissues integrate host-microbial signals and regulate immune responses has a critical impact on health and disease. However, our understanding of tissue immunity is limited because of difficulties in accessing the different organs and also due to the inherent complexity and individuality of the cellular circuits present in different tissues. This conference will bring together scientists in the fields of mucosal immunology, neurology, microbiology, metabolism and systems biology. The conference will discuss (i) the diversity of tissue resident T cell subsets and their function and regulation, (ii) the regulation and role of mucosal B cell responses, (iii) the role of the nervous system in the regulation of tissue immunity, (iii) how tissues integrate metabolic and microbial cues to determine which type of immune response to mount, (iv) the existence of innate memory and its role in pathophysiology, and (v) new approaches in the study of tissue immunity. Because of the interdisciplinary nature of the conference and its focus on tissue immunity across organs and cell types, the conference will give investigators a broad perspective on tissue immunity and encourage them to go beyond the traditional disciplinary boundaries. An interactive workshop engage will engage industrial partners to define new approaches to prevent and treat inflammatory disorders and cancer and will highlight new frontiers in tissue immunity, cellular networks and inter-tissue communication in health and disease.

Public health relevance
PROJECT NARRATIVE The understanding of how tissues integrate host-microbial signals and regulate immune responses has a critical impact on health and disease. Our understanding of tissue immunity is limited because of difficulties in accessing the different organs and the inherent complexity and individuality of the cellular circuits found across tissues. This conference is designed to be interdisciplinary by nature and with its focus on tissue immunity in different organs and cell types, the conference will give investigators a broad and integrated perspective on the immune system and encourage them to go beyond the traditional disciplinary boundaries.